NONCLASSICAL 21 HYDROXYLASE DEFICIENCY--GENOTYPE AND PHENOTYPE IN WOMEN

The purpose of this study is to clinically and chemically characterize LOCAH in a group of normal and hyperandrogenic women, and to examine genomic DNA from those who may have a mutation in their 21-hydroxylase gene as the cause.